Diagnostics on demand: a biosensor platform for multiplexed small molecule detection

Small molecule detection is central in many biological, medical, and legal domains,
including basic research, clinical diagnostics, environmental monitoring, and workplace drug
testing, among other applications. The most widely deployed diagnostics are
immunoassay-based that utilize antibodies raised against ligand-protein conjugates. These
easy-to-use assays enable applications as diverse as point-of-care diagnostics, in-home
testing, and real-time environmental monitoring in the field. Although small molecule
immunoassays are powerful, they are time-consuming and costly to develop because analogs
of target molecules suitable for conjugation to immunogenic carrier proteins must be
chemically synthesized. New methods that enable the routine creation of small molecule
sensors using native molecules would radically increase the speed and decrease the costs
required to develop new diagnostic tests. The proposed work addresses this by building a
technology that will make developing new small molecule biosensors as easy and reliable as
developing new antibodies. We will accomplish this using a versatile new sensing scaffold –
the plant abscisic acid receptor PYR1. This receptor participates in chemical-induced
dimerization with its binding partner, HAB1. We recently described a directed evolution
pipeline for creating PYR1/HAB1 dimerization (PAIR) sensors and have created sensors for
116 small molecules, including Δ9-THC, 20 FDA-approved drugs, and dozens of natural
products. These sensors can be used to create ligand-regulated genetic circuits, drive
ligand-mediated reconstitution of split enzymes, and rapidly create sensitive diagnostic tests.
While our platform is powerful, improvements in hit rate, throughput, and the chemical
space it can access are needed to empower high-efficiency sensor development; to achieve
this, we will combine strain engineering, high-throughput screening, and computational design.
Our improved pipeline will be used for 1-step isolation of >1000 moderate-affinity sensors of
FDA-approved drugs and other medically-relevant small molecules. 100 of these will be
evolved to high-affinity (nM) sensors by subsequent rounds of directed evolution. In parallel,
we will develop methods for converting these sensors into multiplexable diagnostics. The
technology developed will deliver new tools and methods for developing sensors of
user-specified molecules and open the door to user-specified chemical-regulated processes,
will have broad biomedical relevance and will advance biomedical research and clinical and
environmental diagnostics.

Public health relevance
Low-cost small molecule diagnostics, such as drug test kits for home use, have many biomedical applications, including point-of-care diagnostics, in-home tests, and environmental monitoring. We will develop a new technology that makes it much easier, faster, and cheaper to develop new tests.